Gaze, Head Rotation, and Neuroanatomic Correlates of Reading Errors in Neglect Dyslexia

PROJECT SUMMARY/ABSTRACT
Neglect dyslexia (ND) is an acquired reading disorder associated with spatial neglect (SN), commonly
experienced by right hemisphere stroke survivors. ND causes whole-word omissions of left-sided words and
errors on the left-sided letters of individual words (unilateral paralexias). These two distinct error types can be
explained by dysfunctional egocentric (i.e., viewer-centered) and allocentric (i.e., object-centered) spatial
cognition, respectively. Gaze asymmetry has long been considered a hallmark symptom of SN, and recent
research suggests that it might contribute to these errors. However, no study to date has directly correlated gaze
and reading in this population. Gaze involves the coordination of the head and eyes to orient toward a target.
However, most gaze-related research in SN and ND thus far has required the head to be stabilized at midline.
Therefore, relative contributions of the head and eyes to the asymmetry of gaze in SN and ND is unknown.
Current neuroanatomical models of SN and ND suggest that it is caused by disruptions to the interaction of a
bilateral dorsal attention network, which subserves spatial attention and eye movements, and a unilateral right
hemisphere ventral attention network, which supports arousal, vigilance, detection of novel stimuli, and
reorienting attention to novel stimuli. It is unknown how a network disruption leads to a specific type of ND. In
this project, we will examine the predictive value of gaze on ND reading errors, the relative contributions of the
head and eyes to gaze orientation, and the disrupted neural networks that underlie specific gaze patterns and
egocentric and allocentric ND error patterns. (1) To characterize the association between gaze and reading, we
will conduct two experiments that measure gaze with a wearable eye tracker during single-word reading. We
expect to find a strong correlative relationship between gaze accuracy and reading accuracy in participants with
ND, which would support the potential for the use of gaze metrics for ND diagnosis and classification. (2) To
determine the relative contributions of the head and eyes to gaze deficits, we will conduct an experiment using
eye tracking-enabled immersive virtual reality to measure gaze while manipulating the effect of head rotation.
We expect participants with a greater contribution of the head to have poorer egocentric gaze toward left-sided
words and more whole-word omissions. (3) To identify the neural networks that underlie gaze asymmetry and
reading errors, we will lesion map brain scans of participants with and without ND, then use voxel-wise lesion-
symptom mapping to correlate the degree of lesioned brain areas to gaze accuracy and reading accuracy. We
anticipate that lesions disrupting the dorsal network impair egocentric gaze orientation and associate with whole-
word omissions, and that lesions disrupting the ventral network impair allocentric gaze orientation and associate
with unilateral paralexias.

Public health relevance
PROJECT NARRATIVE Neglect dyslexia, a reading impairment associated with post-stroke spatial neglect, presents a major barrier to regaining functional independence in activities of daily living, work, and leisure participation. The goal of the proposed research is to characterize the mediative role that gaze may have in neglect dyslexic errors. Biometric, behavioral, and neuroimaging data collected will inform basic cognitive neuroscience research on the neural networks that support spatial cognition, and applied neurorehabilitation research aimed at improving the detection and classification of visuospatial deficits such as neglect dyslexia.